Administrative Core

The Administrative Core is committed to making our science and technology cores in biomaterials
engineering and translational research imaging the foundational pillars for sustaining and extending the
outreach and scientific competitiveness of our unique bioengineering COBRE. The Core's
responsibilities are to implement the goals and strategies summarized in the Program Overview that
were devised to transition our COBRE center towards long-term sustainability. The Core will oversee
and manage all funds and proposed core and research activities associated with Phase Ill . This Core
will be the center of business management, scheduling, organizing the annual symposium, statewide
outreach, program development, preparing the annual progress report and communication among
scientific core directors, advisors, the central administration and all COBRE and non-COBRE
participants. PI Naren Vyavahare will direct the Administrative core, with assistance of Program
Coordinators Drs. Roger Markwald and Thomas Borg. Their main responsibilities will be to find ways
to integrate core operations, trouble-shoot, evaluate user metrics, assess progress towards
implementation of the user fee programs, direct the Pilot Project Program and coordinate plans for
seminars and other outreach activities in support of core facilities. Program manager Ms. Adair
Andreasson will handle day-to-day ordering and fiscal issues.The Internal Advisory Committee, the
primary operational arm of the Administrative Core, will meet biweekly to assess progress and
performance of core functions and find ways to improve core usage and develop extramural funding.
Permanent members include the two core directors, three ad hoc Clemson scientists, and one clinician
from Greenville Health System. Members will assist with resolving conflicts, selecting pilot projects, and
distributing access to cores through a voucher program. The External Advisory Committee is composed
of senior scientists with experience in directing core facilities and in the regenerative medicine theme
of our COBRE. They will annually review activities of the Administrative Core and lAC and when
solicited, make recommendations, for improving core performance and programmatic development.
Public relevance—Organizing and sustaining a multidisciplinary bioengineering center brings scientists
from all backgrounds together to develop new ideas and new approaches to therapies that can help
treat or cure human diseases to improve the quality and extend the duration of life.

Public health relevance
The Administrative Core is committed to making our science and technology cores in biomaterials engineering and translational research imaging the foundational pillars for sustaining and extending the outreach and scientific competitiveness of our unique bioengineering COBRE. Organizing and sustaining a multidisciplinary bioengineering center brings scientists from all backgrounds together to develop new ideas and new approaches to therapies that can help treat or cure human diseases to improve the quality and extend the duration of life.